Developmental acquisition of memory-phenotype CD8+ T cell function in infection and cancer

PROJECT SUMMARY/ABSTRACT
In unprimed specific pathogen free and germ-free mice, there exists a population of αβ CD8+ T-cells that
exhibit hallmarks of agonist ligand encounter, termed CD8 memory phenotype (CD8-MP) cells. These cells
account for ~10% of the CD8+ T cell repertoire in adult mice, have a CD44hiCD122+ phenotype, display other
memory markers shared by ‘true memory’ CD8+ T cells (CD8-TM) generated in response to pathogen challenge,
and have incompletely defined functions. Previously, CD8-MP cells were thought to develop in the periphery due
to subthreshold T-cell receptor (TCR) signaling to non-cognate self-antigen and in response to cytokine signaling.
However, recent work from our lab demonstrated that CD8-MP differentiation is a robust and conserved TCR-
instructed process driven by the recognition of agonist self-ligands in the thymus and consolidated in the
periphery. Importantly, we also demonstrated that select CD8-MP-biased clones are recurrently enriched in
oncogene-driven prostate tumors and express high densities of PD-1, suggesting a previously unappreciated
role for CD8-MP cells in the immune response to cancer. The objective of this proposal is to define the
immunological mechanisms driving the differentiation of CD8-MP cells and the functional potential imparted by
this process by analyzing CD8-MP functional activity in settings of infection and cancer. We will test the
hypothesis that the differentiation of CD8-MP cells is a two-step process, triggered by the recognition of self-
pMHC-I antigen displayed by medullary thymic epithelial cells (mTECs), followed by sensing of MHC-I and IL-
15 in the periphery, which confer CD8-MP cells with a unique “non-cytolytic” functional profile. In Aim 1, we will
define the antigen presenting cells and accessory signals directing the differentiation of CD8-MP cells at both a
polyclonal and monoclonal level, utilizing our TCR “retrogenic” mouse pipeline and our previously identified
naturally occurring CD8-MP biased clones. In Aim 2, we will identify CD8-naïve and CD8-MP-biased clones
reactive to the same model antigen and utilize our TCRrg pipeline to interrogate the function of these cells
following agonist ligand encounter in a tumor model and in other inflammatory contexts. Elucidating these
mechanisms will provide needed insight into the biology of this prevalent T cell subset and will have key
implications for our understanding of self-tolerance and cancer.

Public health relevance
PROJECT NARRATIVE In mice that have not encountered foreign pathogens, there exists a population of αβ CD8+ T-cells termed CD8 memory phenotype (CD8-MP) cells which account for ~10% of the CD8+ T cell repertoire in adult mice and display hallmarks of immunological memory. Recent work demonstrated that CD8-MP differentiation is a conserved process driven by the recognition of agonist self-ligands in the thymus, and that select clones recurrently infiltrate oncogene-driven prostate tumors, suggesting a previously unappreciated role for CD8-MP cells in the immune response to cancer. Our work will define the mechanisms driving the differentiation of CD8- MP cells and the functional potential imparted by this process, which will have key implications for our understanding of self-tolerance and cancer.